Targeted Gene Therapies for the Prevention of Prosthetic Bypass Graft Failure

ABSTRACT
This scientific proposal addresses the dismal outcomes of prosthetic bypass grafts that are currently used to
treat patients with critical blockages of arterial blood flow in the lower extremities. While the use of greater
saphenous vein conduits for lower extremity bypass surgery is the gold standard, as many as 40% of patients
do not to have adequate quality saphenous vein. Therefore, prosthetic grafts have become widely utilized as an
alternative conduit of choice for lower extremity revascularization. Unfortunately, prosthetic grafts have a
significantly higher risk of failure when compared with vein grafts, which leads to an increased need for multiple
repeat interventions, a predisposition for sudden graft thrombosis, and the ultimate consequence of limb loss.
Prosthetic bypass graft failure is strongly linked to the development of intimal hyperplasia and subsequent
narrowing of the vessel lumen at the anastomotic connection between the artery and prosthetic graft. This
pathologic process disproportionally affects the distal anastomosis and is triggered by an unregulated
overexpression of specific genes, such as TSP-2 and MARCKS, which drive the maladaptive phenotypic
changes of vascular endothelial and smooth muscle cells. We have previously shown the ability to downregulate
TSP-2 and MARCKS expression using small interfering RNA (siRNA) therapy, successfully mitigating the intimal
hyperplastic response after arterial injury. To capitalize on this therapeutic benefit and to ensure clinical
translation and applicability, we have since designed, using CLICK-chemistry, a safe and novel biodegradable
gelatin hydrogel siRNA delivery system that is applied externally around the arterial-prosthetic graft interface
immediately following completion of the surgical anastomosis. Our outside-in method of gene delivery facilitates
full penetration of siRNA through the vessel walls while decreasing the risk of systemic loss to circulation. This
grant proposal centers on further optimizing the efficiency and efficacy of our hydrogel gene delivery platform,
by increasing hydrogel degradation length to 30-days to improve the time of sustained siRNA delivery, increasing
arterial tissue adherence of the hydrogel to prevent mechanical disruption, and promoting unidirectional vascular
delivery to minimize off-target effects to surrounding tissues. We plan to validate the ability of our gene therapy
platform to decrease the intimal hyperplastic response in established models of prosthetic graft failure, namely
rabbit end-to-end and canine end-to-side prosthetic grafting. Secondarily, in the canine model of prosthetic graft
failure, we plan to use state-of-the-art, high-throughput single-nuclei RNA sequencing and spatial transcriptomic
technologies to achieve a more granular understanding of the maladaptive gene signaling pathways occurring
at the arterial-prosthetic graft interface, and establish novel gene targets that can be added to improve and
ensure safe, effective combinatorial siRNA knockdown of the key pathologic genes that are driving prosthetic
graft failure. This work will serve to further the development and use of biomaterials and gene therapies to treat
a longstanding clinical challenge that has plagued the field of vascular surgery for several decades.

Public health relevance
PROJECT NARRATIVE In patients with blockages of major blood vessels that can result in the need for leg amputation, bypass surgery is performed in the leg to surgically reroute blood flow, often relying on the use of a prosthetic tube graft as a conduit to create a new flow channel. A gel capable of prolonged delivery of gene-targeted therapy will be designed and applied around the prosthetic graft connection to the artery, silencing the expression of specific tissue genes that directly cause recurrent disease and blockage of the implanted bypass graft. This technology will improve the long-term success of prosthetic bypass grafts, reduce the risk of limb loss, decrease the overall healthcare cost-burden of this disease, and advance the treatment of cardiovascular disease.